IGF-II regulates lung fibrosis in scleroderma

ABSTRACT
Organ fibrosis is an irreversible endpoint of several diseases, leading to organ failure. Systemic sclerosis (SSc)
is a prototypic multisystem fibrotic disease with fibrosis affecting multiple organs including the lung. SSc has
the highest case fatality among rheumatic diseases and lung involvement is currently the leading cause of
death of patients with this disease. The only available therapeutic option for patients with fibrosis is organ
transplantation, which is clinically impossible on the scale necessary. The hallmark of fibrosis in multiple
organs is the disruption of extracellular matrix (ECM) homeostasis, resulting in accumulation of ECM
components and subsequent organ failure. We identified IGF-II as a gene overexpressed in SSc lung tissues,
whereas in the adult IGF-II is only expressed in the liver. The role of IGF-II in pulmonary fibrosis and in SSc
remains unexplored. We show that IGF-II promotes fibrosis in vitro in primary pulmonary fibroblasts, in vivo in
mouse lungs, and ex vivo in human tissue in organ culture. We also show that IGF-II promotes its effects via
increasing expression of ECM components, tipping the MMP:TIMP balance in favor of a fibrotic milieu, and
inducing expression of TGFb isoforms, thus recapitulating the fibrotic phenotype. We hypothesize that IGF-II
promotes fibrosis via engagement of hybrid IGF-IR/IR receptors, activation of the transcription factors
Egr-1 and Sox9 and subsequent phosphorylation of the scaffold protein NEDD9. We also propose that
increased expression of IGF-II in SSc lung is due to epigenetic regulation. We propose to test our
hypothesis with the following specific aims: 1) Define the factors that promote the IGF-II-mediated fibrotic
phenotype. Specifically we will determine the role of the transcription factors Sox-9 and Egr-1 in orchestrating
the effects of IGF-II and the role of the scaffold protein NEDD9 in mediating the response to IGF-II; 2) Identify
the receptors mediating the effects of IGF-II on fibroblasts by blocking IGF-IR, IR, and IGF-IIR and inhibiting
receptor tyrosine kinase activity; and 3) Examine the regulation of IGF-II gene expression in SSc by examining
if IGF-II mRNA in SSc lung fibroblasts shows biallelic expression and assessing the methylation status of the
IGF-II—H19 locus. Our findings will provide new insights into the pathogenesis of fibrosis in SSc and other
fibrotic disorders and will result in the identification of new targets for the development of therapies. Our
approach will result in findings that are of direct relevance to the human disease, will advance mechanistic
knowledge of the response to IGF-II, and a rationale for targeting IGF-II and/or its receptor(s) as a therapeutic
strategy in SSc.

Public health relevance
NARRATIVE Systemic sclerosis (SSc) or scleroderma is a multisystem connective tissue disease of unknown cause. Lung involvement is currently the leading cause of death of patients with SSc. We propose to identify the role of insulin-like growth factor (IGF)-II, a peptide we identified to be expressed in SSc lung tissues, in promoting pulmonary fibrosis, and the mechanism by which IGF-II induces fibrosis. Our findings will provide a rationale for targeting IGF-II for the treatment of SSc- associated lung fibrosis.